SPINA BIFIDA RESEARCH RESOURCE

The Spina Bifida Research Resource (SBRR) is a patient registry, database and DNA bank that is being developed to provide the data required to undertake a comprehensive study of the factors that influence neural tube development. The SBRR is based on information from individuals with spina bifida and their relatives (parents, sibs, maternal grandparents and maternal aunts). Study subjects are recruited through the spina bifida clinic and the Center for Fetal Diagnosis and Treatment at CHOP.